Roles of host factor protein subnetworks in regulating steps of filovirus infection

RP03 Project Summary/Abstract
Filoviruses critically depend on cellular proteins to facilitate replication and are susceptible to inhibition by cellular
antiviral systems. Research Project 3 (RP03) tests the roles of host protein complexes in virus replication and
establishes an approach to evaluate large datasets for biological importance in virus infection. The work builds
on our genome-wide siRNA, CRISPR-Cas9, BioID, yeast two-hybrid (Y2H), and co-affinity purification plus mass
spectrometry screening data that has identified 100s of host factors that play roles in EBOV and MARV
replication. Traditionally, follow up on such large hit sets has been slow, hampered by assays of sufficient
throughput and informative read-out to provide needed prioritization. Additionally, hits tend to addressed in
isolation, disregarding the relatedness of each hit by function or cellular association. Here, we apply an advanced
computer algorithm, the Prize Collecting Steiner Forest (PCSF) algorithm to associate hit proteins by known,
high confidence, published, protein-protein interaction (PPI) networks. Overlaying virus protein interactions
detected in Y2H and proteomics work revealed clusters of host proteins that interact with a common virus protein.
Furthermore, overlaying highest probability protein function using Gene Ontology (GO) terms from different
databases, revealed clusters of host proteins related by likely cellular function, with actin regulation and RNA
processing being the most over-represented but also pathways related to protein modifications through
ubiquitinylation, sumoylation or phosphorylation being evident (as seen in RP01 and RP02). Based on these
novel findings, we propose the hypothesis that the host factors residing in subnetworks related by common virus
proteins, function or both play the same role in a specific virus replication step. Here, we test this hypothesis by
applying a novel, statistically high powered optical pooled screening platform that phenotypically evaluates
infection outcome by measuring both virus protein and virus RNA expression levels together with subcellular
staining patterns to associate viral functional relatedness to relatedness by known host PPI. This approach
allows efficient prioritization of groups of factors for evaluation by mechanistic assays that identify affected steps
in virus infection and then defining regions of the host and virus proteins responsible for the infection outcome.
The work starts with high priority validated leads representing the actin and RNA processing networks, then
evaluates our existing high stringency network, which is then expanded and enriched through new data fed from
RP01 and RP02. Our team consists of experts with strong track records in performing and analyzing large host
factor genetic and proteomic screens, and performing virus mechanistic analysis. Through extensive interaction
between each group, we expect to gain mechanistic insight into roles for identified host factor protein
subnetworks, which will provide knowledge-based choices for design of interventions targeting these
interactions, for both EBOV and MARV.